Center for Health Equity Research Institute II: Community-engaged biomedical research training and mentored experiences for early career faculty

Project Summary
The goal of this IPERT renewal application, submitted by California State University, Long Beach
(CSULB) Center for Health Equity Research (CHER), is to provide educational and mentored
activities to enhance the readiness of diverse early career faculty at minority serving institutions
(MSIs) to conduct community engaged biomedical research designed to promote health equity.
The proposed CHER Institute II builds on the lessons learned, experiences, and accomplishments
garnered by the original CHER Institute, with the inclusion of a wider range of biomedical
scientists, enhancements to mentor training and mentoring components, additional funding to
support proposal development, and the use of comparator groups to assess outcome evaluation
and inform sustainable models for research training and mentoring. The CHER Institute II will
feature: 1) A six-day, individual and group intensive experience focused on effective community
engaged biomedical research to support participants in the development of a specific aims page
for an NIH proposal, and either an outline of a manuscript for peer-review or the approach section
for an NIH proposal; 2) Regular, mentored support between CHER Institute faculty mentors and
graduated faculty fellows for 12 months following the institute; 3) A highly focused, virtual writing
retreat to continue to develop skills/capacity among alumni who are preparing a submission (or
resubmission) of an NIH grant proposal to include mentoring for up to 6 months, support for one
course buyout or the equivalent, and a peer review prior to submission of their proposal; 4)
Webinars (2 per semester) for 100 early career faculty (including mentored faculty fellows)
annually on theory-based, culturally informed methods and skills development for community-
engaged biomedical research. Institute participants will be recruited from MSI campuses and
affiliated networks using CHER’s database developed during the first CHER Institute, and
through the partnerships established with CHER Institute faculty mentors and alumni. Faculty at
sister MSIs across the U.S. will be given priority, but interested faculty from other institutions
who are working in the area of community-engaged health equity biomedical research may also
apply. The specific aims of the CHER Institute II are:
Aim 1: To develop and implement sustainable models for delivering community-engaged
biomedical research education and mentoring to diverse, early career faculty at MSIs across the
U.S.
Aim 2: To evaluate sustainable models for delivering community-engaged, health equity
biomedical research training and education to early career faculty at MSIs across the U.S.

Public health relevance
Project Narrative The goal of this IPERT renewal application, submitted by California State University, Long Beach (CSULB) Center for Health Equity Research (CHER), is to provide enhanced educational and mentored activities to increase the readiness of diverse early career faculty at minority serving institutions (MSIs) to conduct community-engaged biomedical research designed to promote health equity, including research with basic, clinical, behavioral, and translational outcomes. CHER aims to increase the number of scientists from MSIs represented among National Institutes of Health (NIH)-funded investigators because scientists from MSIs bring unique perspectives and experiences, which are required to successfully diversify the workforce and enhance health equity biomedical research, particularly in the areas of reaching underrepresented minority communities, building trust, healing historical injustices, and enhancing participation in research.